Multidisciplinary Training in Translational Gastrointestinal and Liver Research

This application from Columbia University proposes a postdoctoral training program in the field of digestive and liver diseases. The program is designed to provide research training opportunities for physician-scientist trainees in Gastroenterology-based fellowship programs, to prepare them into becoming independent basic, clinical and translational investigators. The T32 program, takes advantage of many of the existing strengths of Columbia University, including a number of Centers and Departments and the broad framework of research at the university. The Division of Digestive and Liver Diseases in the Department of Medicine has a long record of success, with >80% of the fellows that completed their training currently in academic positions at top universities and medical centers in the U.S., most with external funding. A major strength of the proposed program is the highly collaborative and well-funded faculty, the many recent faculty recruits, as well as the Digestive and Liver Diseases Research Center at Columbia. In addition, the training program builds on the highly academically oriented residency and fellowship programs in both adult and pediatric gastroenterology. We will select our trainees from a very large pool of outstanding applicants to these clinical training programs. Dr. Timothy C. Wang is the PI and Director of this training program, ably assisted by Associate Director Dr. Howard Worman; and both have actively mentored young basic and clinical scientists for many years with superb track records in training. They are assisted by other members of the Executive Committee and supported by both Internal and External Advisory Committees. Trainees have a wide choice of mentors in basic GI, basic liver, or clinical/epidemiological research, and in addition to exciting research projects, they also complete a rigorous program of didactic instruction that includes cross training and multidisciplinary education. Many of our trainees will pursue training by taking relevant courses or enrolling in Patient Oriented Research (POR) and obtain a Masters (MSc) degree. Key milestones for our trainees will include publications, especially first-authored papers, and applications for career-development awards such as K awards and later R01 awards. The training program and associated departments have a well-established seminar series and journal clubs/workshops, career development and mentoring program, and an efficient feedback and evaluation system. In summary, this is a highly successful research training program of physician-scientists in digestive and liver diseases.

Public health relevance
Digestive diseases continue to account for hundreds of thousands of deaths per year at an annual cost of about $140 billion and there remains a shortage of physician-scientists in the field who can (i) identify new strategies for treatment and prevention, as well as (ii) replace researchers with medical degrees who will retire or choose to leave the area of patient care (Dall T, Reynolds R et al Global Data PIs for AAMC, 2024). A critical mass of trained physician-scientists is therefore imperative (Akefe et al Postgrad Med J. 2025) to bridge science and clinical care, and to translate novel advances to patients in clinics. Our training program is dedicated to achieving these objectives since it seeks to train physicians in the design and execution of high-quality clinical and patient-relevant research in digestive and liver diseases.